Probenecid for Alcohol Use Disorder

SUMMARY
The premise prompting this 12-week clinical trial paired to a human laboratory study is based on the direct
evidence from our preliminary work with probenecid, first conducted in a preclinical model of alcohol use disorder
(AUD) (R01AA028982, Alcohol Alcohol 2019) and then, in a human laboratory study testing probenecid when
co-administered with alcohol (R21AA027614, ACER 2024). The scientific rationale for testing probenecid in AUD
was derived by the well-known mechanism of action of probenecid as a pannexin 1 channel inhibitor, its role in
alcohol-induced extracellular adenosine release, and that this process is promoted by a history of exposure to
excessive alcohol. The preclinical work demonstrated that probenecid is able to reduce alcohol consumption in
alcohol-dependent rats. The human alcohol-drug interaction study demonstrated that probenecid did not altered
the pharmacokinetics parameters and the neuropsychopharmacological responses of alcohol. We also
demonstrated that probenecid was able to reduce acute alcohol craving. The goal of this application is to replicate
findings previously conducted in our rodent and human studies and to understand mechanistically the role of the
pannexin 1 channels for reducing the inflammation process in AUD. To achieve this goal, this study proposes a
12 week, between-subject, double-blind, randomized controlled trial (RCT) with probenecid (2g/day) compared
to placebo in 120 individuals with AUD. There are three aims in this study that test the hypothesis that probenecid
compared to placebo, decreases: acute alcohol craving in an alcohol cue reactivity procedure (Aim 1), alcohol
craving (Aim 2) and alcohol consumption (Aim 3) during the overall 12-week trial. We also included an
Exploratory Aim to further shed light on potential mechanism of probenecid effect in reducing alcohol craving
and consumption, that evaluates pro- and anti-inflammatory markers (cytokines, hormones and factors) pre- and
post-treatment. The proposed research is significant because, holds the potential to evaluate the role of a novel
pharmacological target (pannexin 1 channels) in a full-powered RCT and provide the possibility to discover a
novel AUD therapeutic opportunity. This study also will be the first to assess the efficacy of probenecid for AUD
in an integrated behavioral and clinical setting.

Public health relevance
PROJECT NARRATIVE Although many patients have benefited from existing medications for alcohol use disorder (AUD), their effects are moderate or not effective in some individuals. Future efforts in the development of medications for AUD need to include: establishing new targets for drug development; using validated animal models to test medication for AUD; and developing biomarkers to help predict drug response. In addition, if possible, it is important to utilize medications familiar with the clinical practitioner community which will facilitate the inclusion of these medications into the alcohol treatment process.